Regulatory T cells maintain immune homeostasis through translation control

PROJECT SUMMARY
The immune system needs to distinguish between self and non-self, and between pathogen and
commensal. In part it does through the function of regulatory T cells, a specialized subset of CD4 T cells that
are critical for maintaining immune homeostasis, as well as maintaining tolerance toward self-antigens. Their
importance to maintaining peripheral tolerance was illustrated from experiments of nature in both humans (IPEX
syndrome) and mice (scurfy mutation) where loss of this subset of T cells results in the onset of fatal
autoimmunity. Treg dysfunction has also been found to play a role in autoimmune diseases such as type 1
diabetes and multiple sclerosis.
Tregs have the ability to potently suppress CD4 effector T cells (Teff) either directly or through the
modulation of antigen presenting cells (mainly DCs) to ultimately suppress activation, proliferation, and
subsequent effector functions of Teff cells. Several mechanisms have been proposed for Treg-mediated
suppression, including release of suppressive cytokines and expression of inhibitory receptors. However, very
little is known mechanistically as to the effect of suppression on Teff cell function. We found that Tregs promoted
a significant drop in overall translational activity of CD4 Teff cells. Rather than inducing a global, non-specific
translational shutdown in Teff cells, Tregs induced a specific remodeling of the translatome, with several mRNAs
whose transcription was unaffected no longer present on ribosomes. These data provide novel insights into
Treg function and identify new pathways that are potentially available for therapeutic intervention. The goal of
the studies in this proposal are to determine the molecular mechanisms that underlie Treg-mediated translatome
remodeling in Teffs, and to ask whether this mechanism is altered in human autoimmune disease. To achieve
this we will: determine the role of RNA and RNA-binding proteins in Treg-mediated suppression of translation
(Aim 1) and determine the role of translation control in human Treg function (Aim 2).

Public health relevance
PROJECT NARRATIVE Regulatory T cells (Tregs) are a specialized subset of T cells, regulated by the transcription factor FOXP3, that control peripheral tolerance. A failure in their ability to control self-reactive T cells in the periphery leads to autoimmunity, causing immunopathology and tissue dysfunction. We have discovered a novel mechanism for Treg-mediated suppression, and the studies in this proposal will provide mechanistic insights into this process and provide important data for the potential identification of new therapeutic pathways.